Inhibiting Multi-Functional ALDOA for Cancer Therapy

Fructose-bisphosphate aldolase A (ALDOA) is an ancient, highly expressed gene that has acquired three
distinct cellular activities. The best understood activity is catalyzing a key step in aerobic glycolysis. ALDOA
also has protein binding activities independent of its catalytic activity (“moonlighting”), that include binding to
cytoskeletal proteins, which use an “EΦE” motif that fits into a “moonlighting pocket” of ALDO. Binding to the
cytoskeleton actin holds ALDO in an inactive form until it is needed, when it is released by an increase in the
levels of its substrate fructose-1, 6-bisphosphate and/or by growth-factor-induced PI-3-kinase activity. Another
moonlighting function of ALDOA is its presence in the nucleus of cancer cells, where it is associated with
increased proliferation. One possibility is that nuclear ALDOA binds to the EΦE motif on EID-1 in the nucleus
to inhibit HIF-1's transcriptional co-activator, p300. ALDOA levels are increased in many cancers, particularly
pancreatic cancer, where it has been linked to poor patient survival and an increase in metastasis. Pancreatic
cancer cell has high levels of anaerobic glycolysis that is further increased by the hypoxia inducible
transcription factor-1 (HIF-1). HIF-1 induces ALDOA and other glycolytic enzymes that in turn maintain high
HIF-1 activity through an AMPK/p300-dependent feed-forward loop. HIF-1 activity leads to VEGF release and
angiogenesis, and the induction of other cancer cell survival mechanisms. Increased glycolysis provides
hypoxic cancer cells with an increased supply of energy (ATP) and essential metabolites for biomass
synthesis. Elevated ALDOA is also associated with low E-cadherin, a component of cancer cell tight junctions
(TJ) necessary for cell-cell interactions, giving a more mesenchymal phenotype and increased tumor
metastasis. This most likely is due to binding of ALDOA to the EΦE motif of cytoskeleton actin causing its
polymerization and disassembly, or other inactivation of the TJ with loss of E-cadherin. All this makes ALDOA
an exceptional druggable anti-cancer target. Our X-ray crystallography studies have identified a new role for
the C-terminal domain of ALDO in its catalytic activity, as well as a reactive Cys289 residue that allows
allosteric regulation of catalytic activity. We have identified a novel lead probe allosteric inhibitor of ALDOA
that forms a complex with Cys289 inhibiting glycolysis, HIF-1 activity and the proliferation of cancer cells, and
in vivo inhibits glycolysis and tumor growth in a tumor xenograft model. Using this biologically stable allosteric
inhibitor as a lead, one of our goals is to make more potent inhibitors that bind to the allosteric site Cys289, as
well as high affinity bifunctional inhibitors that simultaneously engage the active site and moonlighting pocket.
We will use X-ray crystallography to help us design inhibitors that modulate nuclear regulators of HIF-1 activity;
and not least to design direct inhibitors of ALDOA catalytic activity. We will use these compounds as
pharmacological probes to inhibit the various activities of ALDOA, and as potential leads for new therapies for
the treatment of pancreatic, and other cancers.

Public health relevance
ALDOA is a critical gene for cancer growth and metastasis. It has three activities: energy metabolism, stimulation of metastasis, and activation of transcription factors that cause tumor growth. Using X-ray crystallography we have identified binding pockets on ALDOA for each of these activities that we can block with small molecules. This will allow us to study the contribution of the ALDOA's different activities on tumor growth, and to develop new classes of drugs to treat some of the most aggressive and currently untreatable tumors.